α-Synuclein strain properties are associated with diagnosis of and progression to Parkinson's disease with dementia

Dementia with Lewy Bodies (DLB) is the 2nd most common dementia illness after Alzheimer’s disease, by
definition is associated with deposition of aggregated alpha-synuclein in the cortex and is identified as a research
priority under the Alzheimer’s Disease Related Dementia’s program. Parkinson’s disease dementia (PDD) is one
of the DLB’s and is diagnosed when an individual develops dementia more than a year after onset of the motor
symptoms of Parkinson’s disease (PD). Up to 1/3 PD patients will have cognitive impairment (PD-CI) at the time
of diagnosis and more than 80% become demented over the course of their disease, having progressed from
PD-normal cognition (PD-NC), to PD-MCI (Mild CI) and then PDD. This progression, however, is variable with
20% of individuals with PD-NC or PD-MCI after 15 years and the rate of PDD, amongst those who do develop
dementia, is highly variable. PDD is particularly debilitating because patients can also suffer from delusions and
hallucinations, together leading to significant cost in quality of life and increased mortality over PD alone.
Determining the association between pathological markers and PDD clinical presentation is crucial for
understanding the pathogenesis and developing more effective symptomatic and disease-modifying therapies.
Pathogenic α‐syn transmission has been strongly implicated in mediating pathology spread in a stereotyped
fashion from the gut to the brain, with α‐syn pathology in the cortex driving development of dementia. Recent
studies support the notion that pathogenic α‐syn may behave in manner similar to strain-specific prions that
exhibit distinct biochemical and pathologic phenotypes. These different strains may underlie the heterogeneity
in α‐synucleinopathies, and perhaps the variability observed in the onset and progression of cognition
impairment (CI) in PD. However, the association between the properties of α‐syn strains and CI in PD is
significantly limited. We propose to use an established protocol to amplify α‐syn aggregates by using the
template of pathological α‐syn from the CSF samples of our PD-NC and PDD patients, and identify, define and
segregate different α‐syn strains by biophysical and biochemical methods and cellular and animal assays. We
will compare the strain properties between different cognitive strata in both a cross-sectional (Aim 1) and
longitudinal (Aim 2) analysis, to evaluate the extent to which α‐syn strains change with and predict development
of PD-MCI and PDD. We will then apply these same methods to gut and brain autopsy tissue from individuals
with PD and a gut-brain alpha-synucleinopathy mouse model (Aim 3). We will determine the association between
the properties of characterized α‐syn strains and CI in PD. The overarching goal of this project is to determine if
PD-MCI and PDD strains and the strain conversion can be developed as biomarkers for the onset and
progression of CI in PD. Successful completion of our Aims will mainly identify new markers for predicting the
onset and progression of CI in PD, but also uncover the pathogenesis of dementia in PD, discover promising
targets for disease modifying and generating novel experimental models.

Public health relevance
Pathogenic α‐synuclein behaves in a manner similar to strain-specific prions, exhibiting distinct biochemical and pathologic phenotypes, which underlies the heterogeneity in dementia in Parkinson's disease (PDD). We identified and characterized two distinct α‐synuclein strains from the cerebrospinal fluid (CSF) samples of PD and PD-cognitively impaired (PD-CI) patients, and the preliminary results indicate the α‐synuclein strain properties are specifically associated with PD-CI, and the longitudinal strain conversion occurs before the cognitive decline. This proposal seeks to determine if PD-CI strain properties and the strain conversion can be developed as biomarker for the onset and progression of PD-CI.